Modification of DNA Polymerase d by a Novel Mechanism During Replication Stress

Cancers with germline or somatic mutations of BRCA1/2 have compromised DNA repair pathway, homologous recombination (HR) deficiency. These cancers have a unique response to PARP inhibitors and consequently BRCA1/2 mutations are markers to determine treatment options for breast and ovarian cancers. There is an urgent need to identify additional markers in all cancers that indicate deficiency in HR and consequently application of PARP inhibitors for these cancers. The DNA homologous repair pathway requires many proteins and enzymes to coordinate the repair of DNA double-stranded breaks. Among them, a DNA polymerase is essential for the key step of D-loop extension. In this application, we hypothesize that a specific form of DNA polymerase δ, Pol δ4, is required for HR. Thus, cancer cells without Pol δ4 are HR deficient and sensitive to PARP inhibition. The hypothesis is based on our work in characterization of the enzymatic properties of Pol δ4, especially the ability in strand displacement synthesis. Indeed, it has been shown that the majority of small cell lung cancer (SCLC) cells lack Pol δ4, which is also supported by our preliminary data. The main goal of this project is to test our central hypothesis that Pol δ4 is the key form of polymerase that can perform D-loop extension to facilitate homologous recombination repair of DNA double-stranded breaks. Cancer cells deficient in Pol δ4 are HR deficient and amendable to PARP inhibition. Specifically, this project will 1) Establish that Pol δ4 is required for homologous recombination and the consequences of Pol δ4-deficiency to genomic stability; 2) Characterize the unique response of Pol δ4 deficient cells to chemotherapeutic agents and PARP inhibitors; 3) Elucidate the regulation of D-loop extension by Pol d4 by 3’-5’ helicases, including BLM, WRN and DHX9. The proposed research is innovative as we employ multidisciplinary approaches that include cellular studies and enzymatic characterization to elucidate the underlying mechanisms of Pol δ4 function in D-loop extension. The insight from how changes in subunit composition of Pol δ affect its function in DNA replication and repair is innovative. Completion of this proposal will be a significant contribution to our understanding of how DNA damages lead to carcinogenesis due to alteration of Pol δ quaternary structure. The results in this proposal can potentially change clinical practice in cancer treatment and define a new class of cancers that can be treated with PARP inhibitors.

Public health relevance
The identification of novel markers for DNA repair defects in cancer is an unmet clinical need. Increasing evidence demonstrates that DNA repair deficiencies in cancer define clinical responses to treatment regimens. Cancers deficient in homologous recombination repair have a unique sensitivity toward PARP inhibition as well as immunotherapy. The proposed research validates a potential novel marker of DNA repair defect and fulfills the central mission of NIH to detect, diagnose and treat disease and disability. !